Investigating aberrant vesicular degradation and lipid metabolism in neurodegeneration

BOSCO/MASSI – ABSTRACT
Profilin-1 (PFN1) is an actin-binding protein that is best known for its role in regulating cytoskeletal dynamics. In
2012, we identified mutations in PFN1 that cause the uniformly lethal neurodegenerative disease amyotrophic
lateral sclerosis (ALS), however, the mechanism underlying PFN1-mediated ALS remains poorly understood. To
address this knowledge gap, our team has established and/or characterized multiple ALS-PFN1 models,
including human induced pluripotent stem cells (iPSCs) and knock-in mice with an ALS-linked PFN1 mutation,
both of which allow for investigation of ALS-linked PFN1 at physiological expression levels. Further, we have
established methods for isolating recombinant PFN1 variants for structural studies using NMR and for examining
the molecular dynamics of PFN1 in complex with relevant binding partners. Through our collaborative research,
the Bosco and Massi laboratories uncovered defects in phagocytic vesicular degradation in iPSC-derived
microglia cells. The phagocytosis, autophagy and endolysosomal pathways all entail vesicular degradation with
a convergence on the lysosome. Notably, our study identified a novel interaction between PFN1 and
phosphatidylinositol 3-phosphate (PI3P), a lipid that is essential for autophagy and that is involved throughout
the vesicular degradation pathway. Based on these observations, we hypothesize that mutant PFN1 impairs
autophagy and vesicular degradation through a gain-of-toxic interaction with PI3P and potentially other PIPs
involved in vesicular degradation. The goals of this proposal are to interrogate this hypothesis using PIP-specific
probes and modulators in multiple ALS-relevant cell types (Aim 1) and through biophysical binding and structural
analyses of PIP/PFN1 complexes within biologically relevant membrane contexts (Aim 2). Our preliminary
lipidomics data also revealed lipid dysregulation in ALS-PFN1 mice that may be relevant to disease
pathogenesis. Intriguingly, several of these lipids also regulate autophagy. In Aim 3, we will examine potential
links between autophagy impairment and specific classes of lipids in models of ALS-PFN1 and TDP-43 that are
associated with both ALS and the related disorder frontotemporal dementia (FTD). Collectively, the outcomes
from these Aims will provide novel insight into PFN1-mediated ALS and unprecedented structural information on
PFN1/PIP complexes. We will also gain broad insight into mechanisms of lipid dyshomeostasis and their link to
vesicular degradation in ALS and ALS/FTD, with the goal of identifying interventive strategies that will mitigate
lipid dyshomeostasis in these disorders.

Public health relevance
BOSCO/MASSI- NARRATIVE Deficits in vesicular degradation have emerged as a critical feature of neurodegenerative disease, including in amyotrophic lateral sclerosis (ALS), frontotemporal dementia (FTD), and ALS/FTD. The proposed research aims to elucidate the mechanisms underlying impaired vesicular degradation caused by ALS-linked PFN1 in disease-relevant, central nervous system cell types. Mechanisms of dysfunction that will be studied include lipid dysmetabolism and altered interactions between mutant PFN1 and phosphoinositides, which are potentially important yet understudied ligands of PFN1 that play critical roles in vesicular degradation.